Core D: Data and Informatics Service Core

PROJECT SUMMARY
Hypothesis-testing studies designed to understand the evolution and durability of B and T cell responses in the
contexts of alloreactivity, tissue residency and viral infection that are described in this proposal will rely on several
`omics and other data-rich approaches and corresponding analyses. To support use of these platforms and their
associated data analyses, we propose to provide unified and integrated data and informatics services in the
Data and Informatics Service Core (Core D). The core will cover two broad areas as reflected by the Specific
Aims: data management, including clinical data integration, and bioinformatic and statistical data analysis, both
primary (standardized pipelines) and downstream. In Specific Aim 1, we propose to oversee and implement data
management processes and systems applied to both raw and derived data as well as its integration with
corresponding clinical characteristics of human donors. These efforts will support raw-to-figure analytical
provenance and will benefit the Program by creating infrastructure that can be efficiently used by all the Projects
and Cores as well as promoting good data stewardship practices which in turn, support reproducibility. In Specific
Aim 2, we propose to implement standardized workflows to cover all of the high-throughput platforms used in
this Program (by one or more Projects and data generated by one or more Cores), including bulk B and T cell
receptor repertoire sequencing, single-cell sequencing applications (gene expression, VDJ, feature barcoding
for surface phenotyping and antigen specificity, spatial transcriptomics, multiome), analysis of antibody reactivity
profiles and other assays. This will benefit the Program by standardizing primary data processing across the
Projects and will promote comparability of results. Additionally, we will provide collaborative downstream
bioinformatics, analytical and statistical support for all three Projects. This will benefit the Program by serving as
a resource that all Investigators in the Projects can access for using data analyses to address their hypotheses,
and by centralizing this function, we will economize this support as the analytical needs and methodologies of
the Projects will overlap. To develop this Core, we have assembled a strong team with experienced leadership
and talented individuals with demonstrated expertise in all of the areas covered. Combining these two broad
areas into a Core will maximize efficiency, standardize processes, and promote scientific synergy across the
Program.